Spinal cord functional connectivity as a biomarker of spinal cord dysfunction

Project Summary / Abstract
This proposal aims to (1) develop and evaluate functional magnetic resonance imaging (fMRI) methods to non-
invasively detect functional networks in the human cervical spinal cord at 7 Tesla, and (2) characterize spinal
cord network dysfunction in patients with relapsing remitting multiple sclerosis (MS). Nearly all MS patients have
focal lesions throughout the spinal cord, yet the majority of studies do not investigate disease progression in
the clinically eloquent yet largely unexplored spinal cord. Currently, no imaging technique can predict disability
progression referable to the spinal cord, severely limiting the development of new treatments to slow or halt the
advancement of central nervous system diseases affecting the spinal cord.
Thousands of blood oxygenation level dependent (BOLD) fMRI studies over two decades have provided a
wealth of knowledge on the functional architecture of healthy brains and have explored how brain networks
may be altered through aging, injury, or disease. We have published that spontaneous BOLD ﬂuctuations also
exist in the spinal cord, and have demonstrated that, like the brain, spinal cord activity at rest is organized into
distinct, synchronized functional networks. In the spinal cord, ventral and dorsal resting state networks reﬂect
function of the motor and sensory pathways, respectively. The precise functioning of the spinal cord in normal
and pathological populations, however, remains poorly understood even though studies of connectivity and spinal
cord plasticity using methods other than MRI have been topics of intense research for over two decades. The
scarcity of spinal cord fMRI studies mainly reﬂects the technical difﬁculties of performing fMRI in the spinal cord,
a general lack of appropriate methods and coils, and the need for higher spatial resolution and greater sensitivity
for imaging the spinal cord compared to the brain.
We hypothesize that resting state spinal cord networks are impaired in MS patients with spinal cord lesions,
and spinal cord network dysfunction as measured by resting state fMRI predicts disease progression in this cohort
of MS patients. This proposal will therefore develop an updated 7 Tesla acquisition protocol for high-resolution
spinal cord MRI with signiﬁcant improvements to both data quality and spatial coverage (Aim 1); validate the new
protocol by quantifying within- and between-session reproducibility of spinal cord connectivity in healthy subjects
(Aim 2); and measure the reproducibility of spinal cord connectivity in MS patients, and quantify the predictive
ability of baseline spinal cord functional connectivity on disease progression (worsening of Expanded Disability
Status Scale metrics) after 24 months (Aim 3). Upon completion, we will understand the role of spinal cord
functional connectivity as a novel technology that is complementary to established anatomical and functional
methods currently used to study the brain and spinal cord. These techniques may also be used to investigate
functional changes in spinal cord injury and other diseases of the central nervous system such as transverse
myelitis, primary progressive MS, and amyotrophic lateral sclerosis.

Public health relevance
Project Narrative This project will develop and evaluate novel magnetic resonance imaging methods to non-invasively detect and characterize functional networks in the human cervical spinal cord. Measurements of spinal cord functional connectivity may be used clinically to predict disability progression referable to the cord in multiple sclerosis. These techniques may also be used to investigate functional changes in spinal cord injury and other diseases of the central nervous system such as transverse myelitis and amyotrophic lateral sclerosis.